Metabolomic Analysis of Primary Human Meningioma and Schwannoma following Radiation Therapy: A Novel Approach to Identify Targetable Radiosensitive Pathways

Abstract
Together, meningiomas and schwannomas account for approximately 45% of all primary intracranial
neoplasms. In most cases, these tumors can be treated with surgical resection and/or radiation with good
outcomes. However, when those treatments fail no further options exist. Metabolomics is the study of
metabolic networks, which are critical for tissue phenotype and function and represent a common downstream
pathway from genes, RNA, and proteins. Few efforts have been made to characterize the metabolomics of
most central nervous system (CNS) neoplasms, including meningiomas and schwannomas. Doing so can
provide insight into novel therapeutic targets. The objective of the proposed work is to leverage our access to
many primary human tumor specimens to characterize their metabolomic profiles before and after radiation.
We hypothesize that 1) radiation induces specific metabolomic changes in meningiomas and schwannomas,
and 2) these changes arise from alterations in targetable metabolic pathways. Results from these studies will
facilitate our long-term goal to identify key metabolic pathways in meningiomas and schwannomas that can be
therapeutically targeted to limit tumor growth and increase the efficacy of radiotherapy. Doing so could
dramatically improve both the duration and quality of life in some of our most difficult patients.

Public health relevance
Project Narrative Meningiomas and schwannomas, which account for approximately 45% of all primary intracranial neoplasms, have no good treatments if first-line surgery and radiation fail. Metabolomics—a recently popularized method to study tissue metabolism—has contributed to recent discoveries in multiple tumor types, but almost no literature exists addressing metabolomics in meningiomas or schwannomas. Here we propose to leverage our access to many primary human tumor specimens to characterize their metabolomic profiles before and after radiation, with the goal of finding key metabolic pathways that could be targeted therapeutically.